Targeting the B Cell Response to Treat Antibody-Mediated Rejection

ABSTRACT
Antibody-mediated rejection (AMR) of solid organ transplants is the leading cause of immunologic graft injury,
shortening the half-life of transplants and consequently of transplant recipients. This immunologically mediated
process depends on B lymphocyte activation with differentiation to plasma cells (PC) that produce antibodies to
the donor organ. Once established, antibodies have proven difficult to eradicate. Establishing an effective and
safe way to treat patients with established AMR would potentially increase the half-life of transplanted organs,
extend the lives of patients, and reduce the need for re-transplantation, ultimately increasing the number of
patients who could receive life-saving organ transplants. Our lab has described an effective therapy in a non-
human primate (NHP) sensitized model of kidney transplantation for lowering donor-specific antibody (DSA) and
preventing injury from AMR. The treatment depends on PC depletion in combination with germinal center
disorganization which together lower alloantibody levels. Dual targeting of the immune system by complementary
drugs is based on NHP and human data using a proteasome inhibitor and belatacept. B cell activation and
differentiation is inhibited at the same time that PC are depleted. Consequently, DSA declines, inflammation in
the kidney resolves, and renal function stabilizes. The impact of this intervention on infection risk is not well
defined but is anticipated to increase. We propose to measure the impact of therapy on both HLA-specific and
pathogen-specific B memory cells and PC. We hypothesize that there is a hierarchy of susceptibility to therapy,
with protective immunity being more resistant than allogeneic B cell memory. We will evaluate the impact of the
regimen on T-cell function focusing on cytomegalovirus (CMV). Current therapy of late AMR using therapeutic
plasma exchange (TPE) and intravenous immune globulin (IVIG) with or without rituximab has shown variable
results and frequent rebound of DSA. A low level of evidence supports the efficacy of these treatments, implying
a tremendous need for well-conducted clinical trials to guide treatment of AMR. We propose a Phase I/II
randomized, controlled, prospective interventional study of AMR in human kidney transplant patients using
combined carfilzomib/belatacept (C/B) therapy with TPE and IVIG compared to TPE/IVIG alone. Outcomes will
include the clinical impact of therapy on AMR using the recently validated iBox score for AMR assessment and
the number and type of infections using standardized definitions of infection. We will measure the impact of
therapy on HLA and pathogen-associated B memory and PC as well as CMV-specific polyfunctional T-cells. We
will assess computational digital imaging analysis of AMR non-visual biopsy features to assess whether machine
learning algorithms can improve on Banff criteria of AMR to better guide treatment and predict clinical outcome.
Since late active and chronic active AMR have such a poor prognosis for kidney transplant patients, we believe
that this trial is ethically justified and would potentially yield important safety and preliminary efficacy data that
may lead to improved immune management of transplant patients.

Public health relevance
PUBLIC HEALTH RELEVANCE / PROJECT NARRATIVE End stage renal failure represents a massive health care problem for the United States, affecting 650,000 Americans every year, and having a mortality associated with dialysis of 65% within 5 years. $42 billion is spent annually for hemodialysis. Kidney transplantation dramatically reduces the cost of caring for such patients and improves their lifespan. Improving the outcomes of kidney transplantation and prolonging the survival of transplanted kidneys and patients is a major public health goal.